Native American Youth Cardiovascular Disease Prevention: Implementation of Culturally-Tailored Evidence-Based After School and Home Visitation Programs for Healthy Eating and Physical Activity

PROJECT SUMMARY – Project 3
Urban Native American communities experience significant and persistent disparities in cardiovascular
diseases, obesity and diabetes, and their preventable behavioral precursors, diet and physical activity. This
study implements two multi-level evidence-based interventions (EBIs) Minnesota NET-Works and Stanford
GOALS in partnership with six American Indian after school programs and community-serving organizations in
the Minneapolis, St Paul and Duluth Minnesota. Adoption and maintenance of these programs can be
enhanced and effectiveness strengthened through a structured, evidence-based participatory approach that
tailors the interventions to meet the cultural, organizational contextual, and broader socioeconomic context and
incorporates local innovations. This proposal is poised to achieve these goals through a community-based
participatory research (CBPR).Coalition including the healthcare provider Minneapolis Native American
Community Clinic (NACC, primary care system), Minneapolis and St Paul and Duluth Minnesota School
Districts' Indian Education after school programs (school system), the social service provider Division of Indian
Work's Family Spirit Home Visitation program (social service provider system), departments of public health
and University of Minnesota researchers. The Coalition will use the evidence-based 10-step Getting to
Outcomes (GTO) tailoring and implementation approach to enhance implementation fidelity, reach and
acceptance, and sustainability among the after school programs and community-serving organizations. Native
American organization leadership and program delivery staff will receive mentoring and training in the tailored
EBI curricula and in effective implementation strategies. Implementation strategy effectiveness will be
assessed using a stepped wedge study design. The study uses the Social Ecological Model as its multilevel
intervention framework, and RE-AIM as its implementation process evaluation measurement framework.
Implementation outcomes include organizational leadership support, staff implementation capacity, and
intervention fidelity (program reach, intervention content, delivery, receipt and dose). An important innovative
aspect of the proposed research is its use of evidence-based implementation strategies to strengthen the
capacity of the programs and staff to implement the interventions with broad reach, high participation, and
strong fidelity by aligning with local culture and context. The proposed project will use proven effective
implementation strategies to build program organizational leadership and program delivery staff
implementation capacity to successfully engage urban Native American families in strengths-based, culturally-
grounded programs to promote youth physical activity and healthy eating. Sustained program engagement
among urban Native American families will promote healthy eating and physical activity behaviors that will
reduce future cardiovascular disease risk in this highly burdened community.

Public health relevance
PROJECT NARRATIVE - Project 3 This project will use proven effective implementation strategies to build program organizational leadership and program delivery staff implementation capacity to successfully engage urban Native American families in strengths-based, culturally-grounded programs to promote youth physical activity and healthy eating.